A novel platform for nonribosomal peptide discovery

Project Summary.
Natural products are the major source of drug molecules. Currently, 64% of small molecule drugs approved by
the Food and Drug Administration are natural products or their derivatives. Currently, the dominant technique for
discovering novel natural products is bioactivity-guided isolation. However, this technique is limited to the high
abundance of molecular products of microbial / plant species. Since most of the widely expressed natural
products (NPs) have already been picked, bioactivity-guided techniques now lead to high rediscovery rates of
known molecules. This proposal focuses on developing a novel platform for discovering natural product small
molecules by integrating genome mining with computational metabolomics. With the advent of high throughput
tandem mass spectrometry, metabolomics datasets collected on the supernatant of microbial / plant species
have become available. However, computational techniques for identifying novel small molecules from these
large and complex datasets are in their early stages. Recently, we developed Dereplicator, Dereplicator+, and
molDiscovery to identify known small molecules by searching their tandem mass spectra against public chemical
databases such as PubChem. In phase I of this proposal, we developed VInSMoc, a novel mass spectral
database search method for the systematic discovery of novel variants of natural product small molecules. The
overarching goal of this proposal is to develop NatDiscovery, efficient and accurate methods for identifying novel
non-ribosomal peptides from complex mass spectral datasets. We will further apply methods developed in this
proposal to discover novel non-ribosomal peptides from 1588 Actinobacterial strains. Twenty NRP with novel
chemistries/enzymes will be isolated and characterized at Blumberg Institute, and we will screen them for
antibacterial, antifungal, and antitumor activities.

Public health relevance
Project Narrative. Natural products are an important source of antibiotics, antitumor, and antifungal small molecules. Currently, high-throughput technologies for elucidation of the structure of small molecules are not available. This proposed project will allow us to accurately and efficiently discover novel natural products from complex microbial / plant datasets.